Improving Pain and Sleep Outcomes for Veterans with Chronic Pain

Background: This application is for a five-year Career Development Award (CDA) to support my transition to
becoming an independent VA health services researcher.
Career plan: To successfully achieve my career goal of improving Veterans' health and quality of life by
enhancing the reach and effectiveness of behavioral sleep interventions, I need further mentored training and
content expertise in chronic pain and health services research, including qualitative methodologies, pragmatic
randomized trials, and implementation science, including social marketing theory. I will achieve these
objectives through formal coursework, seminars, clinical training, and mentorship from Melissa Polusny, PhD
(primary mentor; Minneapolis VA Health Care System, MVAHCS), Erin Krebs, MD, MPH (MVAHCS), Michael
Vitiello, PhD (University of Washington), and Hildi Hagedorn, PhD (MVAHCS).
Research plan: Specific aims include 1) understanding the experience of sleep treatment in comorbid chronic
pain and insomnia, 2) optimizing cognitive behavioral therapy for insomnia (CBT-I) delivery for patients with
chronic pain and insomnia, and 3) increasing demand for CBT-I among patients with chronic pain and their
primary care providers. Projects include a qualitative interview study with patient and CBT-I provider dyads
following completion or drop-out from CBT-I to inform hypotheses about strategies to eliminate barriers to
adherence. I will use these findings to draft a package of adherence-promoting adaptations for patients with
chronic pain. A pilot feasibility study will be used to finalize the adherence package and test feasibility of trial
procedures to prepare for a future pragmatic randomized clinical trial. The final project is a local
implementation study to test a social marketing campaign to increase demand for CBT-I among patients with
chronic pain by increasing patient and primary care provider awareness and positive attitudes toward CBT-I.
The social marketing campaign developed in this study will be an important component of a multifaceted
implementation intervention that will be tested in a future multisite trial.
The first two projects will result in a package of adherence-promoting adaptations to be added to CBT-I for
patients with chronic pain. It is likely that components of the adherence package will inform broader efforts to
enhance CBT-I adherence in all patients with insomnia, both those with and without chronic pain, as well as
adherence to other cognitive behavioral therapies. The final CDA project will result in a social marketing
campaign designed to increase demand for CBT-I among patients with chronic pain. We expect that
components of the social marketing campaign can also be used as part of broader campaigns to disseminate
CBT-I widely among patients with insomnia, leading to higher-rates of guideline-concordant care.
Significance and innovation: CBT-I is a highly effective and safe treatment for improving sleep and pain
outcomes and represents a promising alternative to pharmacologic treatments for pain and sleep, which are
associated with serious adverse events. The proposed research utilizes intervention mapping and social
marketing theories to identify evidence-based strategies to increase demand and optimize CBT-I delivery for
patients with chronic pain. This work is responsive to calls by VA and national/international organizations to
address barriers to full implementation of CBT-I and to enhance adherence to cognitive behavioral treatments.

Public health relevance
I am applying for five years of mentored training and research. The proposed training and projects address a critical gap in chronic pain care. Cognitive behavioral therapy for insomnia (CBT-I) is a highly effective and safe treatment for improving sleep and pain outcomes, yet is severely underutilized among patients with chronic pain. Evidence suggests that even if patients with chronic pain initiate CBT-I, they have difficulty adhering to treatment recommendations due to pain-specific barriers. The proposed research focuses on increasing demand and optimizing CBT-I delivery for patients with chronic pain. We expect that findings will have a broad impact on CBT-I dissemination and adherence, as well as adherence to cognitive behavioral therapies in general. I will obtain mentored training in qualitative research, pragmatic randomized trials, implementation science, and content expertise in chronic pain. This award supports my long-term career goal of improving Veterans' health and quality of life through effective sleep treatments.